Dissecting neoepitope-specific clonal T cell populations in advanced melanoma patients vaccinated with personal neoantigen peptides partnered with local and systemic immune checkpoint Inhibition

Project Summary
Our long-term goal is to provide melanoma patients with therapies that produce safe, effective, and
durable tumor control. Immune checkpoint blockade (ICB) with anti-PD-1 and anti-CTLA-4 antibodies is
approved for the treatment of melanoma, however a large subset of patients has primary or secondary
resistance to these agents. Cancer Vaccines provide an opportunity to generate new and amplify existing
antigen-specific T cell responses focusing the immune response against tumor cells and potentially
synergizing with immune checkpoint blockade. Neoantigens are a promising novel class of cancer
vaccine targets created by the personal mutations found in each patient's tumor because they are
exquisitely specific to the tumor and not subject to central tolerance. Recently, in patients with high-risk
melanoma, we demonstrated proof-of-concept of the safety, feasibility, and immunogenicity of a personal
neoantigen vaccine utilizing synthetic long peptides and the TLR3 agonist poly-ICLC (called NeoVax).
We now propose a phase 1 clinical trial in patients with advanced melanoma that seeks to enhance the
efficacy of NeoVax at 3 critical nodes of the tumor immune response by i) admixing NeoVax with the
mineral oil-based immune adjuvant Montanide (improved formulation), ii) administering the anti-CTLA-4
antibody Ipilimumab adjacent to the vaccine injection site (enhanced priming), and iii) partnering the
vaccine with the PD-1 directed antibody Nivolumab (re-invigorating T-cells infiltrating the tumor). We
propose innovative immunological analyses to understand the activity of the modified vaccine and
Nivolumab utilizing serially collected blood and tumor biopsies. In addition to standard bulk profiling of T
cells, we will characterize T cell receptor (TCR) repertoires by sequencing T cell receptors in single
peripheral and tumor infiltrating T cells for clone-paired TCRα and TCRβ chains, and screening of paired
TCRs against vaccine epitopes to identify cognate neoantigens of each TCR. Finally, we will use single
cell RNA-sequencing of the same tumor infiltrating T cells to determine their activation state and
determine if tumor-reactive T cells adopt unique states, and to monitor changes in activation before and
after therapy. Our studies will help identify the critical neoantigens, T cell receptors, T cell activation
states and immune subpopulations that underlie immunity against tumors in the clinical trial. We will thus
determine the impact of Nivolumab relative to neoantigen vaccination on the induction of anti-tumor T
cells, determine the immunogenicity of the selected neoantigens and provide insights for improving the
design and analysis of future neoantigen vaccine trials.

Public health relevance
Project Narrative While immunotherapy, and particularly immune checkpoint blockade, has led to substantially improved outcomes in melanoma and other cancers, innovative combinatorial approaches are now needed to overcome primary and secondary resistance to these new therapies. The goal of this application is to leverage our recent work demonstrating that neoantigens can be therapeutically targeted in cancer patients by testing a personalized vaccine in combination with 3 agents aimed at enhancing vaccine efficacy in patients with advanced melanoma. By assessing clinical endpoints and by interrogating vaccine-induced T -cell responses with leading edge single cell-based technologies, we expect to learn about safety and therapeutic efficacy of this combined vaccine and to gain deep insights into the immunogenicity of neoantigens contained in the vaccine in relation to therapy, thereby potentially improving outcomes and informing future trials in patients with melanoma and other cancers.